Cleveland Kidney, Urology and Hematology Training Network

To improve human health, students must emerge from their scientific training with skills, which will enable them to address unmet health needs with effectiveness, efficiency and economy. Their success depends on their ability to work in interdisciplinary groups and consortia, to understand concepts across the spectrum of laboratory to clinical and public health sciences, and to implement advances in clinical and community settings. The Kidney, Urology and Hematology (KUH) Division of NIDDK has challenged its community to redesign its research training programs to meet these needs. In response, the Cleveland Kidney, Urology and Hematology Training Network (KUH-TN) will identify promising MD and PhD predoctoral and postdoctoral fellows and to provide them with the intellectual and methodological tools to accelerate discovery and its translation for treatment and cure of kidney, urologic and hematologic diseases within an interdisciplinary environment embedded in an ecosystem of
mentorship and peer and near-peer learners. The Cleveland KUH-TN has access to the scientific expertise, infrastructure, support services and programs at two universities, Case Western Reserve University and Cleveland State University and four affiliated academic health centers. In addition, the KUH-TN has strong support from the Cleveland Translational Sciences Collaborative. To accomplish our mission and address the needs of modern scientific research training, we propose the following specific aims:
1. Create a Training Core (TL1) that embraces interdisciplinary learning by identifying themes that cross K-U-, and H-silos, executes research-intensive training using hand-on project, didactics and peer interactions to develop domain competence the prepares KUN-TN trainees for career success.
2. Develop a Professional Development Core that enhances trainee competitiveness in research by ensuring trainees acquire foundational skills for state-of-the-art scientific inquiry. Learning opportunities will happen in the classroom and by informal peer interactions using in person and virtual platforms. This core will further support trainee acquisition of domain competence by providing training to mentors in best practices.
3. Implement a Networking Core to develop a KUH-TN community using in-person and virtual platforms and social events that includes trainees, their peers, and the training faculty and an outreach program to undergraduates and high schools to increase the future KUH-TN candidate pool. This program builds on existing successful partnerships, which engage underrepresented groups.
The KUH-TN will be managed by the Administrative Core, which oversees program organization, governance, collaboration, communication, as well as evaluation and continuous improvement.
In summary, we believe our outstanding training faculty, broad choice of research projects and strong mentoring make our proposed KUH-TN attractive for the best applicants to pursue training in a multidisciplinary community of learners, which bring innovative approaches to address the challenges of KUH research training.
To improve human health, students must emerge from their scientific training with skills, which will enable them to address unmet health needs with effectiveness, efficiency and economy. To meet these needs, the Cleveland Kidney, Urology and Hematology Training Network will provide modern training for future scientists to address outcomes important to people with kidney, benign urinary and benign blood conditions and cure these diseases.

Public health relevance
To improve human health, students must emerge from their scientific training with skills, which will enable them to address unmet health needs with effectiveness, efficiency and economy. To meet these needs, the Cleveland Kidney, Urology and Hematology Training Network will provide modern training for future scientists to address outcomes important to people with kidney, benign urinary and benign blood conditions and cure these diseases.